Programmed necrosis regulation of leukemic transformation.

Background and Innovation: Myelodysplastic syndrome (MDS) is a group of bone marrow failure disorders
with a high propensity to evolve into acute myelogenous leukemia. Although patients present early with low blood
counts (cytopenias). Current therapies target advanced disease; response rates are low and overall survival is
poor. One of the strongest risk factors for MDS is advanced age, and a prominent feature of aging is chronic,
low-grade inflammation, (inflammaging). In Vanderbilt’s Electronic health record database, we find an
association between MDS and both auto-inflammatory disorders as well as pneumococcal pneumonia, sepsis,
and latent viral infections such as HSV as EBV (mononucleosis) suggesting the possibility that prior infection or
chronic inflammation may potentiate MDS.
Thirty percent of MDS patients harbor inactivating mutations in the TET2 gene that are associated with poor
outcome. TET2 is a critical epigenetic regulator and is a key factor in downregulating inflammatory responses.
Data from mouse models harboring Tet2 inactivation in hematopoietic cells, has established a causative role for
inflammation induced by treatment with bacterial products [1] or cytokines [2] [3] in hematopoietic clonal
expansion, a hallmark of MDS disease progression. How Tet2 inactivation alters the immune response to
common human pathogenic insults such as infection and the impact on hematopoietic stem cell function is not
well understood and is critical to devising early intervention strategies.
RIPK1(Receptor Interacting Protein kinase ), a pharmacologically targetable serine/threonine kinase, is a critical
signaling mediator of inflammation downstream of death receptors as well as the pathogen sensing receptor,
TLR4[4]. RIPK1 mediates inflammatory cell death (necroptosis) in hematopoietic stem and progenitor cells[5,
6]. RIPK1 and necroptosis signaling is increased human MDS patient bone marrow samples, most prominent in
the erythroid islands [7]. In the setting of TLR4 signaling, RIPK1 binds to the adaptor, TRIF, to activate NFkB
and pro-inflammatory gene expression[4]. Data from mouse models demonstrates compromised hematopoietic
stem cell function following bacterial infection [8], mediated by direct pathogen sensing by hematopoietic cells
through TLR4. RIPK1 is therefore situated at the nexus of critical signaling pathways directing the response of
hematopoietic stem cells to pathogens and cytokines.
We hypothesize that prior bacterial infection promotes chronic inflammation in the setting of Tet2-deficiency
through epigenetic and inflammatory changes that alter innate immune memory, leading to prolonged and
inefficient response to subsequent infections, chronic inflammation (inflammaging) to promote clonal expansion
and disease progression. Inhibiting by inhibiting RIPK1 kinase function will inhibit the establishment of aberrant
innate immune memory, to prevent infection -related chronic inflammation thereby inhibiting clonal expansion
and disease progression.
Significance to the health of Veterans: MDS is of particular concern in the Veteran population as
approximately 46% of Veteran’s are age 65 or older, relative to 15% of the general population [9]. In the
Department of Veteran’s Affairs (VA) Midsouth Healthcare Network (VISN9), the estimated incidence of MDS
based on an ICD-9 code denoting cytopenias (given for patients with MDS or concern for MDS) is five-fold higher
relative to patients of a similar age in the general population (314 vs 23- 65 per 100,000). Currently, the only
curative MDS therapy is allogeneic bone marrow transplant inaccessible for the majority of veterans due to co-
morbidities and/or lack of a suitable donor.
Path to translation/implementation: If successful, this proposal will provide proof of concept studies for
establishing RIPK1 as a therapeutic target for early MDS, fulfilling VA-ORD translational pipeline stage T0-2 and
consistent with VA research strategic priority #2, to increase the substantial real-world impact of VA research.

Public health relevance
Project Narrative Myelodysplastic Syndrome (MDS) is a malignant disease of blood forming bone marrow cells that is more prominent in the Veteran population. MDS bone marrow loses production capability causing bone marrow failure and has a high probability to evolve into Acute Myelogenous Leukemia (AML). Thirty percent of MDS patients harbor inactivating mutations in the gene TET2 that are associated with poor outcome, but not all individuals with TET2 mutations develop disease. Current therapies target late, symptomatic disease- and outcomes are poor (median survival is 1.6-3 years). Chronic inflammation and infection promote disease progression. We hypothesize that TET2 mutations promote create an increased and prolonged inflammatory response to infection to promote disease. This proposal will test whether interrupting TET2driven inflammation by inhibiting RIP1 kinase can prevent infection-associated disease progression.